Targeting parathyroid glands with novel fluorophores for intraoperative imaging

Project Summary/Abstract: Parathyroid glands (PGs) are often difficult to locate intraoperatively due to their
small size and poor contrast under the surgical light. Recently, surgeons have been using near-infrared (NIR)
autofluorescence as a means to help identify PGs, however, there are false positives and negatives with this
technology and room for improvement in sensitivity and specificity. There is an unmet need to develop a reliable,
bright NIR probe that can be utilized to 1) identify and preserve normal PGs during thyroid surgery, thus reducing
postoperative hypocalcemia complications and 2) identify parathyroid adenomas during parathyroidectomy for
patients with hyperparathyroidism. Therefore, an intraoperative imaging method to help surgeons find PGs in
real-time while preserving normal tissue represents an unmet clinical need, with no available contrast agents.
Our hypothesis guiding this study is that halogenated NIR fluorophores provide sensitive, specific, and real-
time image-guidance for improved therapeutic interventions, including noninvasive localization and
intraoperative image-guided parathyroidectomy. Under the previous NIH funding #R01EB011523, we have
developed over 850 novel NIR fluorophores tailored to endocrine imaging (endocrine-specific NIR fluorophores;
ESNFs) and successfully targeted thyroid/parathyroid glands (TG/PG), pituitary glands, thymus, adrenal glands,
pancreas, and their tumors. Sharing structural and chemical similarities with naturally occurring hormones and
drugs, ESNFs could provide high contrast on endocrine glands for image-guided surgery after a single
intravenous injection into mice, rats, and pigs (see Preliminary Data).
Under the current NIH/NIBIB funding (#R01EB022230; Image-guided drug delivery for neuroendocrine
pancreatic tumor), we have successfully developed a series of oxazine derivatives for targeting pancreas and
pancreatic neuroendocrine tumors. Interestingly, many of these agents show specific uptake in other endocrine
glands including PGs. Therefore, in this renewal application, Therefore, in this renewal application, we aim to
investigate the targeting mechanism of these fluorophores along with their pharmacokinetics/pharmacodynamics
and safety studies. Using the “Structure-Inherent Targeting” strategy, our goal is to increase the specific affinity
of targeted fluorophores while minimizing nonspecific uptake in the thyroid, lymph nodes, or fatty tissues of the
neck, with no overt off-target adverse effects. Specific Aims are focused on three key areas: 1) systematic
optimization of the final formulation with preparative scale-up synthesis, 2) molecular target identification and
pre-operative imaging of primary hyperparathyroidism in tumor mice, and 3) evaluation of the targeted contrast
agents for intraoperative image-guided tumor surgery. We propose to intensify clinical translation activities during
the second award period, including scale-up chemistry and two species toxicity evaluations.

Public health relevance
PROJECT NARRATIVE: Primary hyperparathyroidism is caused by a parathyroid single adenoma in almost 90% of cases and is usually cured surgically. Although preoperative localization such as sestamibi SPECT/CT and intraoperative PTH blood tests have greatly improved surgical therapy of primary hyperparathyroidism in patients, there is still no capability for real-time, intraoperative navigation to localize parathyroid glands during surgery. Furthermore, it is imperative that surgeons identify and preserve normal parathyroid glands during thyroid surgery to avoid postoperative hypocalcemia, where invisible near-infrared fluorescent light can provide sensitive and specific guidance during surgery, but only if optimal contrast agents are available.